Adhesive Transient Strain Sensors for Monitoring Post-Cardiotomy Hemodynamics

ABSTRACT
As many as 20% of patients undergoing open heart surgery can have immediate or delayed postoperative
cardiovascular compromise. In the immediate period, cardiac function is often monitored using a pulmonary
artery catheter and an arterial line. This helps prevent problems in cardiac function and output by noting changes
from the information gathered from these catheters that allow immediate assessment and treatment. However,
these devices, particularly the pulmonary artery catheter, present significant risks to patients including fatal
arrhythmias, perforation of blood vessels or the heart, bleeding into the airway, entanglement and thrombus
formation. If the patient is very sick, it is very common to keep this catheter in place for a prolonged period or
exchange it on a regular basis. However, indwelling lines carry a high risk of bloodstream infection and sepsis.
Furthermore, patients typically are kept in bed until the pulmonary artery catheter is able to be removed. To add
to this, the measurement of cardiac output from this catheter is often unreliable and inconsistent. This can make
being able to treat the patient appropriately difficult and potentially dangerous. Our goal of this proposal is to
design, fabricate, and test a device placed on the surface of the aorta and pulmonary artery during open heart
surgery that can provide information on cardiac function, while avoiding the risk of indwelling lines. The
envisioned device will: 1) be easily deployed; 2) avoid risk of infection by being on the surface of the vasculature;
3) provide accurate and precise measurements of cardiac function; 4) provide a long-term postoperative solution
that is safe and easily removable. The core technology will be a highly sensitive crack-based strain sensor that
can be multiplexed into arrays and integrated with transient flexible adhesive hydrogels. Strain sensors
integrated with adhesive hydrogels will measure pressure waveforms and flow rates; data that can be used to
accurately calculate cardiac output. Sensor arrays will be tested using in vitro and ex vivo models to calibrate
measurements with cardiac output. Finally, we will compare the in vivo measurements of flexible strain sensors
with that of pulmonary artery catheters using an acute infarct model in swine. The overall performance of
transient flexible adhesive strain sensor arrays will be benchmarked to pulmonary artery catheters, the existing
standard of care.

Public health relevance
PROJECT NARRATIVE In this proposal, we will design and test both, ex-vivo and in-vivo, a novel sensor array system that will be used to assess cardiac function by providing accurate measurements of blood pressure and flow that can determine cardiac output. This system will be particularly useful after open heart surgery and will mitigate the risks and complications that are seen with use of the traditional pulmonary artery catheter for collecting the same data measurements. We propose that this array system will not only provide more reliable measurements of pressure, flow and cardiac output, but will also be able to safely remain in place for a longer period of time than a pulmonary artery catheter and be easily and safely removed.